Deconvoluting the contributions of the IFNy pathway components to lung TME and tumor immunity

Project Summary
The approval of anti-PD1/PD-L1 and anti-CTLA immune checkpoint blockade (ICB) therapies for those with non-
small cell lung cancer (NSCLC) has demonstrated that immunotherapies can generate robust responses for a
subset of patients with advanced disease. However, while nearly 45% of patients demonstrate a major
pathological response to ICB, the median progression-free survival for NSCLC patients remains dismal at around
7 months. It is now well documented that persistent interferon gamma (IFNy) cytokine pathway signaling plays
a paradoxical role within the tumor microenvironment and has been associated with both resistance and
response to ICB leading us to believe that there is greater nuance to dissect within this pathway. Accordingly,
this cytokine pathway is quite complex as IFNy stimulates the expression of ~200 hallmark interferon-stimulated
genes (ISGs); thus, it is still unclear how the majority of ISGs influence tumor immunity as it has been difficult to
study this pathway in a relevant biologic context. Using a novel functional genomics platform developed in our
lab (Perturb-map) my sponsor lab was able to knock-out (KO) 35 cytokine genes in parallel in the KP mouse
model of NSCLC and investigate spatial and temporal phenotypes at a single-cell resolution. It was found that
KO of Socs1, a negative regulator of the IFNy pathway, caused an overt growth advantage and a paradoxical
increase in both CD8+ and CD4+ T-cell infiltration into tumors. Further, these tumors were found to be more
sensitive to PD-L1 blockade than wildtype tumors. We hypothesize that Socs1 KO causes chronic upregulation
of tumor cell IFNy signaling leading to cytokine-mediated infiltration of the TME which is followed by an increase
in immune-inhibitory signal expression on tumor cells such as PD-L1. In Aim 1, we will investigate the influence
of Socs1 KO on tumor immune-composition of the TME and tumor phenotype using Perturb-map and
transcriptomics. We will then corroborate these data with CITE-seq of human lung cancer specimens to further
explore the role of SOCS1 in human malignancy. In Aim 2, we will use Perturb-map to KO all 162 ISGs and
determine how each impacts tumor immunity in the context of immune checkpoint blockade therapy and TME
biology at depth. These experiments will include assessment of immune & stromal recruitment, tumor
organization & differentiation, and unbiased analysis by spatial transcriptomics to identify mechanistic programs
controlled by each ISG.

Public health relevance
Project Narrative: Although immune checkpoint blockade (ICB) therapeutics have proved the possible efficacy of immunotherapies in non-small cell lung cancer (NSCLC), most patients do not respond to these treatments durably. This proposal aims to use spatial functional genomics in coordination with highly-multiplexed imaging to illuminate the specific roles of SOCS1 and all other interferon gamma (IFNy) stimulated genes (ISGs) in generating an immunosuppressive environment within the tumor microenvironment (TME) and regulating resistance and response to ICB.